Mitochondrial calcium signaling in pancreatic cancer metastasis and progression

The goals of this research plan are to uncover the molecular mechanism by which mitochondrial Ca2+ signaling
promotes pancreatic ductal adenocarcinoma (PDAC) cell migration, invasion and metastasis, and to devise novel
strategies to exploit potential therapeutic vulnerability in metastatic PDAC based on our mechanistic studies.
The Mitochondrial Calcium Uniporter (MCU) is the only Ca2+ channel on the mitochondrial inner membrane
responsible for mitochondrial Ca2+ uptake. Under certain pathological conditions, MCU-mediated mitochondrial
Ca2+ overload leads to cell death. Paradoxically, MCU levels are significantly increased during the progression
of several types of cancer. In this proposal we use PDAC as a model to study the molecular mechanism by which
MCU controls cancer metastasis and progression. Our data indicated that MCU overexpression in PDAC
promotes PDAC cell migration, invasion and metastasis through a MCU-Nrf2 signaling circuit. Through non-
biased RNA sequencing and interrogation of the TCGA transcriptomic datasets, we identified xCT (SLC7A11,
the functional subunit of the cystine / glutamate antiporter system) as a potentially druggable target in MCU-
mediated anti-oxidant response and PDAC metastasis. Intriguingly MCU overexpressing PDAC cells are
addicted to xCT-mediated cystine uptake. When PDAC cells were deprived of cystine or treated with xCT
inhibitors, MCU promotes ferroptosis, a form of lipid ROS-mediated, iron-dependent regulated cell death. In Aim1
we will use genetically engineered mouse model to investigate the role MCU-Nrf2 signaling in PDAC metastasis
and progression. We will determine the mechanism by which MCU activates Nrf2 in Aim 2 and define cystine
addiction as a therapeutic vulnerability in MCU overexpressing PDAC in Aim 3. The success of this proposal will
provide important mechanistic insight for mitochondrial calcium signaling in PDAC metastasis, and will likely
provide a novel avenue to prevent metastatic recurrence in PDAC.

Public health relevance
This project investigates the basic mechanisms by which the dysregulated mitochondrial calcium signaling promotes pancreatic cancer metastasis, which accounts for more than 90% of pancreatic cancer-related death. The anticipated results from this proposal will significantly advance our understanding of pancreatic cancer metastasis, and potentially provide novel strategy for preventing metastatic progression in pancreatic cancer.